Deciphering genome integrity maintenance using cytogenomics

Project Summary/Abstract
Chromosome missegregation leads to aneuploidy and genomic instability—hallmarks of cancer and contributors
to reproductive aging. Understanding how centromere sequence composition, structure, and epigenetic
background influence chromosome segregation is important for unraveling the molecular origins of genome
instability that could promote cancer evolution. Centromeres are specialized chromosomal regions that serve as
sites of kinetochore formation and microtubule binding that partition chromosomes into daughter cells during cell
division. The Gerton Lab at the Stowers Institute for Medical Research, supported by NCI funding
(R01CA266339, Maintaining the integrity of a genome), investigates centromere biology and kinetochore function
to uncover the mechanisms driving chromosome missegregation and aneuploidy. As a Research Specialist II in
the Gerton lab, I design and implement experimental strategies addressing centromere composition, functional
activity, and chromosome dynamics. Our current research investigates how natural variation in human
centromeric array size and activity impacts the accuracy of chromosome segregation. Multiple complete telomere-
to-telomere human genome assemblies exposed centromeres as some of the most variable regions in the human
genome. Centromeres of the same chromosomes can differ between individuals in both size and the epigenetic
determinants of kinetochore positioning. We hypothesize that individual sequence and epigenetic pattern
variations in human centromeres can alter their interactions with cell division machinery, predisposing individuals
to distinct chromosome missegregation events. To test this hypothesis, we are working on mapping the
centromeric sequence landscape and associated kinetochore proteins in individual human centromeres, and
investigating how these variations impact chromosome segregation in cultured cells and tumor tissues. I utilize
cutting-edge genomic and cytogenetic techniques, along with high-resolution microscopy, to measure centromere
sizes and the deposition of inner kinetochore proteins. These data are being integrated with genetic and
epigenetic information from the Telomere-to-Telomere (T2T) consortium, a global multi-lab initiative focused on
generating complete genome assemblies. This collaboration allows our groups to integrate genomic data with
cytogenetics, a method we call “cytogenomics”. This information will be used to find the centromere-specific
genetic and epigenetic signatures influencing the accuracy of chromosome segregation in both cultured cells and
xenograft tumor tissues. Our long-term goal is to develop comprehensive models explaining how centromere
sequences and activities contribute to the rise of aneuploidy and to translate these findings into insights relevant
to cancer biology. This research is innovative because it leverages the latest information on human centromeric
DNA arrays, introduces new models for centromere organization, and employs cutting-edge molecular, genomic,
and imaging tools. The proposed work is significant because it addresses fundamental questions about the role of
innate centromere variation in genomic alterations, providing insights into cancer biology and aging.

Public health relevance
Project Narrative This proposal addresses the genetic origins of aneuploidy and chromosome instability, the key factors in cancer origination and evolution. This project uses advanced imaging, cytogenetics, and genomic techniques to investigate how individual variations in centromeres affect the fidelity of chromosomal transmission. It will improve our understanding of tumor origination and evolution, supporting the NCI’s mission to advance cancer research and treatment.